An Administrative Supplement to Increase the Recruitment Rates of R01 DA047301 a Pivotal Trial of a Novel Digital Therapeutic for Smoking Cessation in Psychiatric Populations

PROJECT SUMMARY/ABSTRACT
This Administrative Supplement to Support Existing NIH Grants and Cooperative Agreements (PA-20-272) will
boost the recruitment capacity of R01 DA047301 to successfully meet the aims of an FDA pivotal trial.
Tobacco use remains at alarming high rates amongst individuals with serious mental illness, such as
schizophrenia spectrum, bipolar, and recurring depressive disorders. Smoking tobacco is the number one
preventable cause of death in this population, shortening the lifespan of adults with serious mental illness by
25 years and contributing to $317 billion in healthcare expenditures and indirect loss of earnings and disability
benefits. Novel and effective models to deliver wider-reaching smoking cessation interventions to individuals
with serious mental illness are highly needed and indicated as a priority for NIH. Digital Therapeutics (DTx) are
a promising method to deliver smoking cessation treatments to people with serious mental illness. Despite
numerous DTx available to use for people with serious mental illness, our feasibility research has
demonstrated that using DTx presents daunting challenges for this population. Based on this work, we
developed Learn to Quit, a user-centered smoking cessation DTx tailored to the needs of individuals with
serious mental illness. The DTx’s main active ingredient is a novel behavioral treatment that has shown
promise as a smoking cessation intervention -- Acceptance and Commitment Therapy. The DTx provides
education about the use of nicotine replacement therapy and recommendations from US Clinical Practice
Guidelines to ensure alignment with best clinical practices. In a pilot randomized controlled trial (R00
DA037276), comparing Learn to Quit versus NCI’s QuitGuide, we demonstrated: (1) high recruitment and
retention rates, (2) high levels of user engagement with Learn to Quit, (3) an effective method to conduct a
large multi-site randomized controlled trial, and (4) promising cessation outcomes. While this developmental
work provides initial evidence of Learn to Quit’s usability, feasibility, and preliminary efficacy, a large scale
randomized controlled trial is needed to test its efficacy in a representative sample of patients with serious
mental illness. Therefore, the proposed pivotal trial will: (1) employ a randomized parallel arm design to
compare the efficacy of Learn to Quit vs. Brief Advice, (2) use rigorous methods to evaluate mechanistic
processes of this DTx, and (3) examine the cost-effectiveness of Learn to Quit compared to a Brief Advice for
this patient population. This pivotal trial addresses a serious problem -- high smoking rates among people with
serious mental illness -- and proposes to test the efficacy of an easily-accessible smoking cessation
intervention using technology with the potential for high population-level reach.

Public health relevance
PROJECT NARRATIVE Smoking tobacco shortens the lifespan of adults with serious mental illness by 25 years and contributes to $317 billion in healthcare expenditures and indirect loss of earnings and disability benefits. In prior work, we launched a pivotal trial to evaluate the efficacy of a digital therapeutic for smoking cessation for individuals with serious mental illness. This Administrative Supplement (PA-20-272) will provide recruitment support to this ongoing clinical trial to generate data that might lead to the FDA clearance of this device as a prescription digital therapeutic.